Socioeconomic impacts of La Crosse encephalitis in western North Carolina

Project Summary
La Crosse virus (LACV, family Peribunyaviridae, genus Orthobunyavirus) is the leading cause of arboviral
pediatric encephalitis (neuroinvasive LACV disease; NLACVD) in the United States (US) and is endemic in
western North Carolina (WNC) and several mosquito species (primary vector: Aedes triseriatus;
invasive/established: Aedes albopictus and Ae. japonicus) are competent LACV vectors. In NC, most cases
occur in WNC within Southern Appalachia, where primary and invasive vectors are commonly found
peridomestically. The economic wellbeing of these rural counties is generally low; with almost all counties
being classified as Tier 1 (most distressed) or 2, which likely contributes to disparities related to low awareness
of risk, poor adherence to personal protection measures, and limited clinical recognition in the absence of
severe disease. While the total number of cases each year is relatively low, socioeconomic (SE) and public
health burden is substantial and long-lasting. Clinical, developmental, and SE impacts of LACVD/NLACVD will
be examined in an endemic area. We will also examine whether incidence of mosquito vectors is associated
with LACVD/NLACVD incidence. We hypothesize that (a) SE impact of LACVD/NLACVD in rural areas is
significant and not known at hospital discharge, (b) there is a need for community education about risks,
prevention, treatment, and recovery resources, and (c) incidence of vectors is related to LACVD/NLACVD. To
examine these hypotheses, we propose the following Specific Aims: Aim 1: Assess acute and persistent
medical, social, and cognitive LACVD/NLACVD impacts. Clinical assessment and survey methods will be
used to assess patient and family perceptions and behaviors related to LACVD/NLACVD. Medical evaluations
will be conducted via chart review (to estimate severity), survivor survey, follow-up (virtual and/or in person)
interviews, and clinical assessment. Aim 2: Determine and quantify economic hardship in
LACVD/NLACVD survivors & families. Interview methods will be used to collect information from
LACVD/NLACVD survivors and family members. Completing this aim will allow us to estimate direct economic
costs such as healthcare (e.g., physical/occupational therapy, mental health counseling, medication),
academic support (e.g., tutoring), and indirect costs (e.g., related travel, missed work, caregiver mental health).
Aim 3: Assess environmental risk factors at LACVD/NLACVD case residences. Laboratory/field methods
will be used related to site assessments (e.g., oviposition sites, land cover) and mosquito collections at case
properties and surrounding areas and/or non-case neighborhoods. This study will fill a gap regarding suffering
of victims and families after illness and will open new possibilities for future research, public education
campaigns, and social/regulatory interventions.

Public health relevance
Project Narrative This project focuses on the socioeconomic impact of neuroinvasive/non-neuroinvasive La Crosse virus disease (most common cause of arboviral pediatric encephalitis in the United States) in western North Carolina. Economic wellbeing may contribute to disparities in risk awareness, adherence to personal protection, and clinical recognition and this relationship will be verified, along with site assessments of mosquito-related risks. Findings are expected to contribute to the development of public/environmental health strategies to intervene to improve risk reduction, treatment, and recovery resources, thereby reducing impact on survivors and families.